Regulation of the Native Protein Landscape in the Nucleus by Molecular Chaperones

ABSTRACT
Homeostasis requires most, if not all, pathways to function rapidly and precisely. While
cooperative interactions between proteins and cofactors helps ensure selectivity, the events
mediating dynamic action are less well understood. Further complicating pathway performance is the
nature of the cell interior, as it is densely packed and often contains multiple binding partners for each
protein—both features increase non-productive or off-pathway interactions. These variables present
great challenges for achieving homeostasis especially in the midst of fluctuating internal and external
stimuli that must be monitored constantly to appropriately initiate, continue, or halt cellular processes.
Hence, biological complexes must be actively and persistently disassembled in order to work on a
useful time scale. We suggest that the broad binding specificity and energy-independent molecular
chaperone activities of the Hsp90 chaperone system govern the kinetic behaviors of the diverse
proteins within cells. Basically, Hsp90 and its cochaperones resolve inherently stable cooperative
complexes into a dynamic machinery capable of rapid action that enables efficient and timely
biological pathways.

Public health relevance
Contact PD/PI: Freeman, Brian C PROJECT NARRATIVE Homeostasis relies on precise and dynamic action by nuclear pathways including RNA transcription, DNA repair, and genome organization. While cooperative interactions between proteins and cofactors helps ensure selectivity, the events mediating the rapid action are less well understood. We believe molecular chaperones, especially the Hsp90 system, foster a highly dynamic nuclear environment that is critical for timely and effective DNA-associated pathways. Page 7 Project Narrative